Discovering Wdfy3 as a novel regulator of macrophage efferocytosis by genome-wide CRISPR screen

PROJECT SUMMARY
Defective clearance of apoptotic cells (AC) by macrophages (efferocytosis) contribute to many diseases
including atherosclerosis. Given the therapeutic potential of genes that regulate efferocytosis, we sought to
identify novel regulators of this pathway in an unbiased manner. We established a genome-wide pooled CRISPR
knockout screen for efferocytosis in Cas9-overexpressing murine bone marrow-derived macrophages. Individual
validation of the strongest screen hits has uncovered Wdfy3 (WD repeat and FYVE domain containing 3) as a
novel regulator previously never implicated in the regulation of efferocytosis or phagocytosis. The goal of this
study is to focus on Wdfy3 for in-depth mechanistic studies of its molecular mechanisms and roles in
atherosclerosis. Degradation of engulfed AC requires the recruitment of a subset, but not all of the autophagy
machinery for LC3 lipidation and subsequent phagosome-lysosome fusion. There remains a significant
knowledge gap to identify which autophagy genes participate in the degradation of phagocytosed cargos. Those
that are not required for non-selective canonical autophagy (“self-eating”) are of particular interest for their
potential of therapeutic targeting for activation. Wdfy3 regulates selective autophagy for clearance of aggregated
proteins, but is dispensable for non-selective canonical autophagy during starvation, making it such a candidate.
Our data show that Wdfy3 knockdown reduces efferocytosis in murine and human macrophages; WDFY3 is co-
localized with engulfed AC; Wdfy3 expression is increased in plaque macrophages during atherosclerosis
regression; in human plaque, WDFY3 expression is correlated with M2-like macrophage markers. Within this
context, we hypothesize that Wdfy3 is required for macrophage efferocytosis by regulating phagosome formation
and maturation and Wdfy3-mediated efferocytosis protects against atherosclerosis in hyperlipidemic mice
models. Aim 1 will determine the molecular mechanisms of Wdfy3 by addressing (A) which stage of efferocytosis
is regulated by Wdfy3; (B) How Wdfy3 is recruited and participates in phagosome formation and downstream
events; (C) whether and how overexpression of Wdfy3 enhances efferocytosis. Aim 2 will determine (A) whether
mice lacking myeloid Wdfy3 have defective efferocytosis in dexamethasone-induced thymic apoptosis and
in advanced atherosclerosis; and whether myeloid overexpression of WDFY3 will enhance in vivo
efferocytosis and alleviate atherosclerosis; (B) whether human iPSC-derived macrophages with WDFY3 null
mutations demonstrate defective efferocytosis and enhanced inflammation. Aim 3 will examine whether other
autophagy genes among the top screen hits are also key regulators of efferocytosis and their dependence on
Wdfy3. This study will (1) reveal novel fundamental mechanisms of efferocytosis regulated by Wdfy3 and the
potential of Wdfy3-mediated efferocytosis as a target for pro-efferocytotic therapy in atherosclerosis, and (2)
provide a broadly-applicable platform for genome-wide screen of complex functional phenotypes in primary
macrophages for unbiased novel discoveries.

Public health relevance
PROJECT NARRATIVE Impaired macrophage efferocytosis drives important diseases including atherosclerosis, whereas enhancing efferocytosis has therapeutic benefits. We have established a genome-wide CRISPR screen for unbiased discovery of novel regulators of macrophage efferocytosis. This study will focus on Wdfy3, a novel regulator discovered by the screen, for in-depth mechanistic studies on its molecular mechanisms and roles in atherosclerosis.